Task B1: Phase I Clinical Trial to Evaluate a Therapeutic for Carbapenem-Resistant Enterbacterales (CRE) Antibiotic-Resistant Infections

The Early Phase Clinical Trial Units provide a vehicle for investigation of new agents in the treatment and prevention of infectious diseases and can carry out all aspects of interventional clinical trial implementation.